Biomarkers of ischemic risk in adults with sickle cell disease

PROJECT SUMMARY
The goal of this work is to use non-invasive quantitative neuroimaging methods to test hypotheses regarding
cerebral oxygen utilization in patients with sickle cell disease (SCD) undergoing current standard treatments as
well as emerging curative and disease-modifying treatments. Completion will improve our understanding of
neurological injury in anemia, which is critical for development of biomarkers that can be used to triage patients
for therapies based on personalized risk profiles as well as evaluate the impact of these therapies on established
indicators of brain health. More specifically, while cerebral oxygen delivery depends on the cerebral blood flow
(CBF; ml blood/100g tissue/minute) and blood oxygen content, it is becoming increasingly recognized that blood
capillary transit time itself can also influence tissue oxygen extraction. In individuals with anemia where
accelerated capillary flow velocities may be present as a result of hyperemia and cerebral autoregulation,
reduced arterial-to-venous transit time (AVTT) can lead to reduced times for tissue oxygen offloading.
Compelling evidence has been provided for such heterogeneous capillary flow underlying abnormal oxygen
delivery in multiple conditions including expansion of infarcts in acute ischemic stroke, traumatic brain injury, and
Alzheimer's disease1. Despite evidence of increased risk for cerebral vasculopathies and stroke, the
mechanisms by which these occur is not fully understood. In SCD, we have observed that rapid arterial-to-
venous transit, visible on arterial spin labeling (ASL) CBF-weighted MRI, is present in more than 50% of adults
and children2, 3. Importantly, we have observed that rapid arterial-to-venous transit is associated with reduced
oxygen metabolism 2, suggesting that these transit times may provide a biomarker of cerebral ischemia in
individuals with SCA who have greater than a 50% risk of cerebral infarcts by age 30 years4, though less than
16% show conventional stroke risk factors. In SCD, decreased AVTT can play a role in the breakdown of the
blood-brain barrier (BBB) through increased shearing forces along the vascular endothelium, and further
potentiate vaso-occulsive crises. Here, we propose to utilize noninvasive neuroimaging methods to assess
hemodynamic changes such as AVTT in SCD across a variety of hemoglobin-altering therapies to provide
quantifiable metrics of expected improvement to triage patients for new or more aggressive therapies.
Furthermore, this project aims to evaluate how rapid arterial-to-venous transit times are related to BBB
permeability, and overall brain health. In Aim (1), we hypothesize that in adults with SCD, there is a linear
reduction in cerebral blood flow and arterial-to-venous flow velocity for treatment-induced increases in Hb. In
Aim (2) of this study, we hypothesize that there is an inverse relationship between cerebral arterio-venous transit
times and circulating markers of BBB impairment.

Public health relevance
PROJECT NARRATIVE Patients with sickle cell disease (SCD) are at high risk for developing cerebral arteriopathies and stroke, with an incidence of overt stroke or silent cerebral infarct (SCI) of 50% by age 30 years, though unfortunately there is no current standard for triaging adult patients for more aggressive therapeutic options such as transfusion and transplant, or for emerging genetic therapies or pharmacological agents. Here, we aim to investigate cerebral oxygen utilization through non-invasive imaging approaches to understand mechanisms of oxygen metabolism and neurovascular dysfunction in anemia, with the long-term goal of using this information as biomarkers to triage individuals with anemia for personalized stroke prevention therapies. Future extensions of this work will allow for the development of specific, novel quantitative measures of elevated blood flow and oxygen utilization and understanding how these measures relate to brain health and treatment response, ultimately informing the development of biomarkers for stroke prevention.